Functional anomaly mapping of aphasia recovery

Project Summary Difficulty communicating (aphasia) is one of the most common and debilitating results of left-hemisphere stroke. Although aphasia symptoms are highly variable and recovery is difficult to predict, much research has shown that lesion size and location are major drivers of aphasia symptoms and recovery. However, this previous research has only considered direct anatomical damage caused by the lesion. This is a critical limitation because stroke lesions also cause indirect effects on the function of brain structures distant from the lesion. Throughout this application, I refer to this as “remote dysfunction.” Although initially thought to resolve quickly after the stroke, remote dysfunction is now known to persist throughout recovery and independently contribute to outcomes. Studies of aphasia recovery have focused almost exclusively on the idea of recovery through reorganization, whereby behavioral improvement occurs through plastic reorganization of brain networks. These studies have eschewed the older idea that recovery occurs through partial resolution of remote dysfunction (RRD) caused by lesions. Consequently, it is not clear how RRD contributes to aphasia recovery. The applicant has developed a new machine learning approach called functional anomaly mapping (FAM) that uses resting BOLD functional MRI signal to map remote dysfunction throughout the brain in individual stroke survivors. FAM maps have much better test-retest reliability than current measures, like task- related fMRI activity and resting state functional connectivity, as well as several other features that make it promising as a clinically useful tool. The applicant has already demonstrated that remote dysfunction measured with FAM relates to behavioral outcomes in people with chronic aphasia. During the mentored phase of this award, the applicant will optimize the FAM approach and test competing hypotheses about the biological mechanisms generating the remote dysfunction measured in chronic aphasia. During the independent phase, the applicant proposes a longitudinal study to understand the contribution of RRD to aphasia recovery. The applicant proposes a comprehensive training plan to expand his knowledge in the following areas: the biological mechanisms of stroke recovery and neuroplasticity beyond aphasia, machine learning, biomarker development, and advanced neuroimaging analysis. The research and training during this award will enable the applicant to develop a long-term, independent research program focused on understanding the neural correlates of aphasia and developing translational brain measures to inform clinical decision-making in aphasia neurorehabilitation.

Public health relevance
PUBLIC HEALTH RELEVANCE: Public Health Relevance Statement Difficulty communicating (aphasia) is one of the most common and debilitating results of left-hemisphere stroke. While aphasia symptoms are highly variable and recovery is difficult to predict, stroke size and location are significant determinants of outcomes. Research that leads to a more complete characterization of how stroke lesions affect residual brain function over the course of recovery will lead to a better understanding of the brain-behavior relationship in aphasia and has the potential to inform clinical decision-making in aphasia neurorehabilitation.